Stability of Odor Representations in the Olfactory Tubercle

PROJECT SUMMARY/ABSTRACT
The brain’s ability to maintain stable internal representations of the external world is critical for consistent
behavior. Yet recent studies show that neural representations can gradually shift over time, a phenomenon
known as representational drift. While initially observed in associative areas like the hippocampus and parietal
cortex, drift also occurs in primary sensory regions such as the piriform cortex, a main site of olfactory identity
processing. This challenges our understanding of how stable odor-guided behaviors persist despite ongoing
neural change. The olfactory tubercle (OT) receives direct input from the olfactory bulb and dopaminergic input
from the ventral tegmental area (VTA), positioning it as a site where odor identity and reward value may be
integrated to support stable representations. However, it remains unclear whether OT representations are
stable or flexible, how they change with learning, and what role dopamine plays in this process. This project will
investigate the temporal dynamics of odor representations in the OT and test whether dopamine contributes to
their stability or flexibility. By conducting this work in the Molecular and Cellular Biology department at Harvard
University, I will be supported by world-class resources and mentorship to elucidate the mechanisms
underlying odor representation dynamics in the following aims. In Aim 1, I will use miniscope calcium imaging
in behaving mice to track OT population activity during a two-alternative forced choice (2AFC) odor
discrimination task. I will assess whether odor representations remain stable during continual reinforcement or
drift when reinforcement is paused. I will then test whether new odors disrupt existing representations, and
whether removing odors from training accelerates drift. In Aim 2, I will selectively ablate VTA-derived dopamine
inputs to the OT using 6-hydroxydopamine (6-OHDA) and examine how this affects drift. I will assess whether
dopamine stabilizes representations during extended training or protects against drift when cue-outcome
training is paused. Finally, I will test whether dopamine depletion impairs or enhances the incorporation of new
odor information, shifting the balance between flexibility and stability in the OT. Across both aims, I will use
statistical and computational tools, including similarity metrics, dimensionality reduction, and decoding models,
to quantify drift and uncover its structure. This work will advance our understanding of how the brain preserves
meaningful sensory representations and how dopamine shapes the trade-off between stability and adaptability.
The activities in this grant will anchor my training in systems and computational neuroscience and prepare me
for a successful research career. To further my development as an independent scientist, I will supplement this
training by presenting my work at national and international conferences, publishing my findings in
peer-reviewed journals, and by training the next generation of scientists through teaching and mentorship.

Public health relevance
PROJECT NARRATIVE The olfactory tubercle (OT) integrates information from the olfactory bulb and ventral tegmental area, combining sensory and reward-related signals. I will determine to what extent the OT maintains consistent olfactory representations and how dopamine reinforcement shapes their persistence over time. Doing so will contribute to our understanding of how the brain balances sensory stability with flexibility to support adaptive behavior.